Alcohol and Hyperprolactinemia

Alcoholism is known to induce hyperprolactinomas, a condition when the plasma level of prolactin is elevated,
in both men and women. Hyperprolactinemia, is known to be one of the major reasons for reproductive
dysfunction such as amenorrhea, galactorrhea and infertility in human. Many of the patients with
hyperprolactinemia also show prolactin-secreting pituitary adenomas (prolactinomas). Pituitary tumors
represent 10–15% of intra-cranial tumors. While most are benign and can be controlled by current
therapeutics, some show a lack of sensitivity to a combination of therapies or recur during follow-up and are
considered as aggressive with unclear epidemiology. About 0.2% of pituitary tumors are associated with
distant metastasis (most frequently in central nervous system, liver and bones) and with a mean survival of
between 1 and 3 years. A significant number of reports now identified alcoholism as a potential contributor to
the development of aggressive tumors in various tissues including pituitary gland. Although the mechanism by
which alcohol promotes aggressiveness of tumors is not known, increasing evidence suggests that aberrant
patterns of DNA methylation, an important epigenetic mechanism of transcriptional control, could be part of the
pathogenetic mechanisms that lead to the development of alcohol-induced aggressive tumors. Using animal
model of prenatal alcohol exposures, which maintains stable alcohol epigenetic marks on the genome, we
identified epigenetic modifications of key regulatory genes that enhances cell stemness in the pituitary. In this
proposal, we test the role of a novel stem cell regulatory developmental pluripotency associated-4 (DPPA44)
gene in mediation of alcohol effects on the development of aggressive tumor in the pituitary. We hypothesize
that alcohol epigenetically modifies the promoter region of DPPA4 gene to enhance oncogenic properties of
this transcription factor in the pituitary under the estrogenic influence that promote the development of
aggressive prolactinomas in prenatal alcohol exposed rats. To test these hypotheses we will employ pituitary
tumor stem cell spheres (pituispheres) to determine if prenatal alcohol exposure enhances the oncogenic
potential of DPPA4 in the pituitary. We will evaluate the potential mechanism contributing to oncogenic
transformation by DPPA4. We will conduct experiments to elucidate the mechanism by which prenatal alcohol
exposure epigenetically modifies the DPPA4 gene to increase its oncogenic property. We will study the
interaction between DPPA4 and dopamine D2 receptor in the promotion of aggressive pituitary tumors and
access the role of interaction between DPPA4 and estrogen receptor1 in the promotion of aggressive pituitary
tumors. We will employ various cellular and molecular approaches, gene editing techniques and genome wide
expression analysis to investigate molecular actions of DPPA4 in mediation of alcohol effects on pituitary tumor
cell growth and progression.Together these studies should establish how alcohol epigenetically programs the
pituitary to overexpress DPPA4 gene and how this transcription factor interacts with dopamine D2 receptor and
estrogen receptor to control the development of aggressive prolactinomas. The information gained from the
proposed studies should lead to development of DPPA4 and dopamine D2 receptor based therapy to control
aggressive tumors in the pituitary.

Public health relevance
The main goal of this proposal is to use rat pituitary tumor progenitor cell model to test the hypotheses if prenatal alcohol exposure enhances the oncogenic potential of DPPA4 by interacting with dopamine D2 receptor and estrogen receptor 1 in the pituitary. The findings of these experiments will form a novel treatment strategy targeting DPPA4 for better prognosis and treatment outcome of aggressive pituitary tumors.